Imaging Dynamics in Anxiogenic Serotonin Circuitry

PROJECT SUMMARY
Serotonin has been long been recognized as an important modulator of mood and behavior, yet it projection-
specific dynamics are little understood. While serotonin has been well studied in anxiolytic contexts, activity of
certain serotonin projections works to increase stress behaviors. In particular, serotonergic projections from
dorsal raphe to the anterodorsal bed nucleus of the stria terminalis have been shown to be anxiogenic. Despite
decades of targeting serotonin, a consensus on serotonin function and release dynamic is lacking.
Pharmacological approaches, microdialysis, and chemogenetic manipulations have produced key insights, but
none provide millisecond resolution for serotonin release and correlates of specific reactions and behaviors
until recently. The Tian lab is in the final stages of developing two serotonin specific biosensors (sLight and
iSeroSnFR) that open the door for new possibilities in serotonin research. I will these sensors combined with
fiber-photometry to optically measure behaviorally driven serotonin release in an anxiogenic serotonin circuit
with high temporal and spatial resolution.
The series of experiments outlined in this proposal are significant because they will: Aim 1) rigorously
demonstrate the in vivo utility of serotonin sensors in dissecting anxiety circuit, providing end users important
protocols and guidelines for fast technological implementation; Aim2) map dynamics of serotonin release in
anxiogenic circuits to stress behavior, and discover how activity in this circuit is impacted in anxious animals
and determine the mechanistic impacts of acute vs. chronic SSRI administration on anxiogenic serotonin
signaling; Aim 3) determine the developmental effects of pubertal testosterone on the maturation of anxiogenic
serotonin activity and SSRI efficacy.

Public health relevance
PROJECT NARRATIVE In this proposal, I aim to apply these two sensors combined with fiber-photometry to optically measure behaviorally driven serotonin release in an anxiogenic serotonin circuit with high temporal and spatial resolution. This information will be made publicly available and become fundamental data to guide future research with the sLight and iSeroSnFr biosensors. I will use these sensors to answer previously unapproachable questions about functional role of serotonin in an anxiogenic circuit and mechanistically address gaps in SSRI efficacy.